TRYPSIN/SECRETIN AND ABDOMINAL PAIN

The purpose of this study is to determine the relationship between the serum trypsin, secretin test and final clinical diagnosis in our GI clinic population. This is a DSL-only protocol.